Urological Diseases in America (UDA) Compendium

The Urological Diseases in America (UDA) project describes various urologic diseases, symptoms, and conditions in the United States. This includes demographic variations in the incidence and prevalence of these conditions, as well as changes that may be occurring over time. The goal of this acquisition strategy is to define the approach for acquiring continuing support services for the UDA project funded by National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK) Division of Kidney, Urologic and Hematologic Diseases (KUH).The UDA Compendium project provides the urological community with documentation and analyses of non-malignant urological diseases, medication, diagnostic tests, treatment outcomes and healthcare costs and dissemination of analytic findings.